High-precision pooled screening for quantitative molecular phenotypes

ABSTRACT
The RNA-guided DNA recognition of CRISPR/Cas9 now enables comprehensive genetic
screening in mammalian cells and other previously intractable systems. CRISPR/Cas9 provides
highly programmable genetic perturbation through DNA cleavage, transcriptional inhibition, or
targeted mutagenesis. Measuring the phenotypes associated with these genetic perturbations
remains a challenge, and this often represents the greatest barrier to mapping the genetic
dependencies of important biological processes.
We propose to develop a general approach that links molecular phenotypes with the targeting
guide RNAs that induce those effects in a large, pooled cell population. We label distinct guide
RNAs with unique nucleotide barcodes that are expressed in an RNA reporter, linking the RNA
abundance of the barcode to intracellular processes of interest. Our system can directly monitor
transcriptional, post-transcriptional, and post-translational responses, allowing us to couple it
with a wide array of intracellular signals. These expression measurements are well suited for
epistasis analysis, which can identify genetic pathways and uncover novel gene functions
through correlated patterns of genetic interaction from quantitative phenotypic proﬁles. We will
make available our validated reagents for implementing this screening approach in budding
yeast and in mammalian cells, providing a broadly useful resource for high-precision genetic
proﬁling.

Public health relevance
NARRATIVE CRISPR/Cas9 screening is a powerful tool for learning which genes are important in a biological process. It can be challenging to measure the effects of inactivating different genes, however. We propose to develop a general toolkit for measuring cellular responses to gene inactivation, enabling more quantitative use of CRISPR/Cas9 in many processes.